Role of Social, Behavioral, and Ecological Processes in Dating Violence

Dating aggression among youth involved with the juvenile justice system (JJS) is an area in
great need of innovation. Not only because of the pernicious course of negative impacts on both
adolescents and their partners, but also because of the intersection with issues ranging from
custody to delinquency to trafficking. To date, knowledge in the field of violence prevention has
been limited by reliance on traditional, self-report instruments that are not designed to capture
risk factors for dating aggression with precision and in real-time. Furthermore, research has not
caught up with the growing influence of online social networks (OSN) on relationship
functioning.
Thus, we will employ a novel combination of online social networking (OSN)
data, ecological momentary assessment (EMA), computer-based, and interview methodologies
to assess the phenomenology of dating aggression among JJS-involved youth. We will recruit a
sample of 300 court-involved, non-incarcerated adolescents (ages 14-18) in current dating
relationships from the Rhode Island Family Court. Adolescents will complete a baseline
assessment and participate in laboratory tasks, followed by a four-week EMA protocol on their
mobile devices. At 4-week follow-up, youth will return devices, permit download of OSN for the
prior 4 weeks, as well as complete self-report assessments. Understanding the interplay of
temporally linked daily assessments and conflictual interactions prior to and following dating
aggression is crucial, both to document the phenomenology of these behaviors among JJS-
involved youth and to lay the groundwork for future interventions that will be able to incorporate
real-time user data with personalized feedback to offset the development of violent episodes in
vivo.
!

Public health relevance
Project Narrative Youth in the juvenile justice system are at high risk for dating aggression and these experiences have significant repercussions for courts dealing with delinquent youth. This study will integrate a novel combination of online social networking (OSN) data, repeated smartphone assessments, and computer-based assessments to understand how dating aggression emerges in real time.